Research Training in Rheumatology at Massachusetts General Hospital

This is the 45th year of this highly successful research training program in Rheumatology at the Massachusetts
General Hospital (MGH) and Harvard Medical School (HMS), supported by this training grant. The goal of this
program is to train MD, MD/PhD and PhD post-doctoral fellows for independent investigative careers in
rheumatology research. Of the 67 trainees who were supported by this training grant, many now have faculty
appointments in academic medical centers, including holding current or prior leadership positions at major
institutions as Deans, Presidents, CEOs, Scientific Directors, and Division Chiefs. Our program centers on our
outstanding clinical Rheumatology fellowship and our strong basic, translational, clinical science and clinical
epidemiology research programs. The MGH Rheumatology T32 Training Program is situated within a vibrant,
technologically-innovative research environment. Our program provides supervised laboratory, clinical and
health outcomes research under the guidance of accomplished faculty members, as well as structured training
in rheumatology, immunology, clinical trials, epidemiology, biostatistics and ethical issues through courses and
conferences. The basic science focus of the program is the immunopathogenesis of rheumatic disease. Areas
of particular interest include autoimmunity, tolerance, innate immunity, leukocyte trafficking, infectious causes
of rheumatic diseases, systems immunology, fibrosis, and cartilage and bone biology. Disease areas of
particular interest include rheumatoid arthritis, lupus, gout, scleroderma, Lyme, vasculitis and IgG4-related
disease. The clinical science research program focuses on population and health care sciences in rheumatic
diseases. This application requests 5 training positions that will be allocated to trainees who are committed to
at least 2 to 3 years of research training. Candidates will be drawn from the MGH Rheumatology fellowship
and from post-doctoral trainees already working in the laboratories of faculty mentors. Twenty-two faculty
members primarily from the MGH Rheumatology Unit and its affiliated Center for Immunology & Inflammatory
Diseases (CIID) participate in this T32 Program. Faculty mentors were carefully chosen based on their track
record of publications, grants, mentoring, collaboration and mutual research interests. The training program
also leverages many MGH research centers, including the Ragon Institute, Center for Cancer Research,
Center for Regenerative Medicine, and Mongan Institute. The MGH provides an outstanding training
environment and is home to the largest hospital-based research enterprise in the U.S., with an annual budget
nearly $2 billion comprising more than 9,500 researchers. Opportunities at Harvard University, including
course work and the NIH-funded Harvard Clinical and Translational Science Center as well as the Harvard
T.H. Chan School Public Health and the Broad Institute provide additional resources for trainees. In sum, in
this renewal application we have created a cohesive, integrated, high-quality training program in basic,
translational, clinical and health outcomes research in the rheumatic diseases.

Public health relevance
Project Narrative Research Training in Rheumatology at the Massachusetts General Hospital is designed to prepare the next generations of research scientists who, through mentored research and rigorous training in new technologies, are prepared to be leaders in rheumatology related biomedical research. The overall goal of this program is to educate trainees so that they can contribute to our understanding of the pathogenesis of rheumatic diseases, and translate these findings to better clinical care for patients with these important diseases.